Role of Cardiomyocyte Function & Sex in Developing Heart Failure with Preserved Ejection Fraction

? DESCRIPTION (provided by applicant): Heart failure with preserved ejection fraction (HFpEF) currently represents half of the ~6 million heart failure patients in the United States. Population studies have repeatedly found HFpEF to disproportionally effect women over the age of 65 at a rate of 2:1 compared to men. The prevalence of HFpEF sharply increases in women after menopause concomitant with higher morbidity and mortality rates. The pathological mechanisms underlying HFpEF, as well as the causes of the unequal distribution among sex, remain controversial and poorly understood. Underrepresentation of women in human and animal studies may be a primary reason for the uncertainty. While evidence suggests that sex hormones may protect the premenopausal heart against cardiovascular disease, the specific mechanisms involved remain elusive. Moreover, the protective role of estrogens against cardiovascular disease, and specifically HFpEF, continues to be controversial. The general purpose of this proposal is to assess if female sex hormones play a protective role on cardiac function in disease, and if their loss exacerbates the development of HFpEF. The specific aims of the proposal are: 1) Determine if the development of HFpEF is delayed in aortic-banded female miniature swine compared to aortic-banded males; and 2) Determine if female sex hormones influence the development of HFpEF. To examine these issues, we will extend our male aortic- banded mini-swine model of HFpEF, which displays key clinical features of the disease, into intact and ovariectomized female mini-swine. I will use an integrated approach to comprehensively evaluate in vivo whole heart cardiac function (pressure-volume loops, ultrasound, myocardial blood flow & oxygen consumption) and pathological remodeling (hypertrophy, fibrosis) alongside in vitro cardiomyocyte calcium handling and contractile function. In summary, this investigation will use a translational large animal model displaying clinical features of HFpEF to elucidate novel mechanisms contributing to the increased susceptibility of post-menopausal women to developing HFpEF.

Public health relevance
PUBLIC HEALTH RELEVANCE: Our research is aimed at understanding why post-menopausal women are more likely to develop heart failure with preserved ejection fraction (HFpEF) compared to men, and if premenopausal women are protected from developing HFpEF. The proposed study will use a translational large animal model displaying clinical features of HFpEF, maximizing the translational nature and clinical relevance of our research. I will use an integrated approach to comprehensively evaluate in vivo whole heart cardiac function and pathological remodeling, in addition to in vitro studies examining individual cardiomyocyte calcium handling and contractile function to determine what differences exist among sexes in the development and progression of HFpEF.